Tyrosine Kinases and Thrombosis

Project Summary
Tyrosine kinase inhibitors (TKIs) are important therapeutic agents to treat various cancers. However, any
agent has a tradeoff between efficacy and on or off target deleterious effects. This notion became evident in
the treatment of chronic myelogenous leukemia (CML) when a potent and broadly inhibitory tyrosine kinase
inhibitor, ponatinib (Iclusig, Ariad Pharmaceuticals, now Takeda) was recognized to have a 31% incidence of
cardiovascular (CV) events of which 21% overall were significant adverse events (SAEs). In a Phase II trial
(PACE) at 4 yrs. the incidence of arterial occlusive events was 26% (myocardial infarction 14%, stroke 11%,
and limb ischemia 11% - some patients have more than 1 organ event). Ponatinib (poni) is one of 5 TKIs
approved for the treatment of CML
We have created a murine model to examine the effects of TKIs on blood coagulation, vascular, and platelet
function. In aged mice treated with the various TKIs under steady-state conditions, ponatinib, unlike imatinib,
demonstrated an increased risk of arterial and venous thrombosis. Poni treatment leads to decreased arterial
occlusion times, larger venous clots and generates hyperactive platelets - features that contribute to
heightened thrombosis. Our laboratory has identified key mechanisms underlying the prothrombotic
phenotype of poni. First, poni-treated mice have increased vessel wall reactive oxygen species (ROS),
apoptosis, and inflammatory vascular lymphocyte infiltrates that expresses coagulation factors V and VIII.
Second, platelets from poni-treated mice are hyperactive to in response to collagen. Additionally, we have
determined that pioglitazone (pio), a PPAR agonist, when given with poni normalizes the vessel wall
inflammation and platelet hyperactivity to correct murine thrombosis risk
The overall hypothesis of this application is that poni-associated thrombosis results from immune cell vascular
inflammation expressing prothrombotic genes and altered platelet signaling resulting in platelet hyperreactivity.
Poni treatment has identified a novel mechanism of prothrombotic vascular dysfunction by which vascular
infiltrating lymphocytes express coagulation enzymes FV and FVIII potentially to contribute to thrombosis. At
therapeutic dosing in man, poni inhibits p-LynY507, a negative regulator of activated GPVI, in both unstimulated
and activated platelets with little effect on p-LynY396 and p-SykY352, suggesting that these platelets may be
more reactive. In fact, poni-treated mice have platelets that react to lower concentrations of CRP. These
defects are genetically and functionally corrected by pio’s genomic and non-genomic PPAR agonism. The
specific aims of the proposal are as follows:
The specific aims of the proposal are as follows: 1) Determine the mechanism of ponatinib- and other TKI-
induced vascular inflammation 2) Identify the mechanisms of poni-induced platelet hyperactivation.
These studies will determine the mechanisms of poni and other TKI effects on vessel wall and platelets that
lead to cardiovascular events. They present a pre-clinical model for poni-associated thrombosis and correction
with pio, a PPAR agonist. Last, they will serve as a paradigm for CVD assessment for TKIs in general.

Public health relevance
Project Narrative The use of ponatinib and other tyrosine kinase inhibitors for CML and other cancers are associated with an increased risk for cardiovascular events approaching 30% of patients. We have observed that ponatinib increases thrombosis risk in rodents by increasing vascular inflammation and inducing hyperactive platelets. In our experimental models, ponatinib use is associated with immune cell vascular inflammation. On RNAseq of aorta, we note increased expressed of genes associated with thrombosis. Further, we have observed increased signaling in platelets. The PPAR agonist pioglitazone corrects ponatinib-induced thrombosis risk and thrombosis gene expression and normalizes platelet hyperactivity. Presently we aim to expand the investigations on the mechanisms by which ponatinib increased thrombosis risk and broaden these investigations to all the TKIs used to treat CML.